The PreVAIL-kIds Common Protocol

Abstract
PreVAIL-kIds sites have iden5ﬁed opportuni5es to rapidly acquire and share samples and clinical data
among themselves, thus catalyzing the process of mul5-site valida5on of their ongoing developmental
assays and algorithms. Via a survey conducted in April 2023, the sites have iden5ﬁed the matrix of
shareable/usable samples and data amongst members of the network. Over 80% of possible exchanges are
going to be frui8ul. The goal of this supplemental applica5on is therefore to facilitate the rapid exchange of
data/samples between the 8 PreVAIL-kIds sites, so that mul5-site valida5on of their respec5ve assays and
algorithms can proceed.

Public health relevance
Narra$ve The goal of this supplemental applica2on is to facilitate the rapid exchange of data/samples between the 8 PreVAIL-kIds sites, so that mul2-site valida2on of their respec2ve assays and algorithms can proceed.